Dissemination & Implementation Science Core

Project Summary Dissemination and Implementation Science Core (DISC)
Despite significant progress in combating HIV, the epidemic remains a formidable challenge both globally and
locally in Missouri, with steady numbers of new HIV diagnoses and deaths each year. To address this ongoing
issue, the Midwest Developmental Center for AIDS Research (D-CFAR) proposes the establishment of a
Dissemination and Implementation Science Core (DISC). The DISC aims to leverage dissemination and
implementation (D&I) science to optimize the use of evidence-based interventions and advance the adoption
and sustainability of HIV interventions, guidelines, and programs. Three primary reasons for the need of this
core are: the region faces entrenched challenges to implementation, Missouri's designation as an End the HIV
Epidemic (EHE) focus area has mobilized resources and momentum, and the presence of world-class D&I
research resources that need tailoring for regional HIV research and public health communities. The DISC
outlines four specific aims: Aim 1. Supplement D&I resources by customizing existing assets to applied HIV
investigators. The core will add HIV-specific content to existing D&I resources, making the field more
accessible to investigators and addressing real-life HIV response scenarios, such as testing and linkage. Aim
2. Provide consultation to support both established and emerging HIV investigators in incorporating D&I
perspectives and methods into their research. Expert guidance will be offered on crucial D&I concepts, and
investigator-centered discussions will aid in utilizing available D&I resources effectively. Aim 3. Enhance
engagement between academic investigators and non-academic stakeholders in the Missouri EHE response.
Through participatory activities and innovation challenges, the core aims to foster collaboration between
academics and practitioners to address EHE priorities in Missouri. Aim 4. Evaluate the impact of DISC
activities using established evaluation frameworks. The evaluation will assess the reach, effectiveness,
adoption, implementation, and maintenance of DISC-wide activities, including scientific productivity and
additional D&I science priorities. The DISC is expected to magnify investments in the existing funded research
base and enhance HIV research efforts at Washington University and Saint Louis University. By supporting
investigators and strengthening academic-practitioner engagement, the core aims to make significant strides in
HIV prevention and treatment, ultimately contributing to the end of the HIV epidemic in St. Louis and Missouri.